Regional Fatty Acid Metabolism In Humans

Project Summary/Abstract
Our goal is to understand the why obesity, and specifically upper body/visceral obesity (UBO), causes
insulin resistance, Type 2 Diabetes and the other health problems. We study what regulates the storage of fat in
adipose tissue and release of free fatty acids (FFA) from adipose tissue (lipolysis) in humans. For this application
we propose to complete five Specific Aims. We will determine whether, in response to an energy deficit
intervention that results in an 8 kg loss of body fat in adults with Class I obesity: 1) preferential upper
body/visceral fat loss will be associated with greater improvements in metabolic health; 2); basal/meal
suppressed lipolysis in UBSQ and LBSQ adipose tissue under baseline and/or active weight-loss conditions is
related to preferential loss of fat from those depots; 3) meal fat storage in UBSQ and LBSQ adipose tissue under
baseline and/or active weight-loss conditions is related to preferential loss of fat from those depots; 4) the
functional (enzyme) and gene regulation responses in UBSQ and LBSQ adipose tissue predicts changes in fat
storage/release; 5) the depot-specific fat loss will be similar in pre- and postmenopausal women. These studies
will offer insights as to whether inter-individual differences in adipose tissue lipolysis or meal fatty acid storage in
adipose tissue are responsible for differential fat loss from lower body and upper body fat. The responses of
different adipose tissue depots to weight loss interventions will provide mechanistic information as part of our
goals of identifying obesity phenotypes that can inform future therapeutic strategies to maximize the health
benefits of weight loss.

Public health relevance
Project Narrative We wish to understand why people who gain excess weight in the abdomen are more prone to diabetes and high blood fats. The fat tissue under the skin in the abdominal area releases excess fat into the bloodstream, which effects how the rest of our body can metabolize sugars. We are proposing experiments that will measure how fat cells in leg and abdominal fat are regulated differently in people who reduce body fat by dietary means, which results in different fat losses.